Characterizing the Pan-genome of a Rickettsia Infecting the Eastern Black-legged Tick

PROJECT SUMMARY
Microbial residents of arthropod disease vectors engender profound effects on the biology of their host, both
positive (e.g., nutrient acquisition, defense from pathogens) and negative (e.g., reproductive parasitism). The
mechanisms that underpin these microbial processes arise as evolutionary consequences of genetic variation and
are often mediated by mobile genetic elements (MGEs). Even when these resident microbes are not known to be
pathogenic, their impact on host biology can influence the distribution and transmission of vector-borne pathogens.
The deer tick, Ixodes scapularis, is widely distributed in the Eastern United States and is an important transmitter of
several human pathogens, including Borrelia species (Lyme disease) and Anaplasma phagocytophilum
(anaplasmosis). Deer ticks also harbor a prevalent intracellular bacterium, Rickettsia buchneri, that is unique among
Rickettsia species in several ways: 1) it is vertically inherited with high efficiency in the deer tick, but does not cycle
between ticks and vertebrates in nature; 2) it is, astonishingly, the only Rickettsia species that has ever been detected
in I. scapularis; and 3) its genome is substantially enriched with pseudogenes and MGEs that carry intriguing cargo,
including genes for biotin synthesis, antibiotic synthesis and resistance, and nonribosomal peptide synthesis. Given
its maintenance in deer ticks, and its arsenal of potential functions, R. buchneri stands to exert significant influence
on the biology of this important disease vector.
The long-term goal of this research is to determine the nature of the relationship between R. buchneri and I.
scapularis. The current work is designed to advance this research goal by addressing significant challenges; namely,
the lack of a high-quality reference genome, inconsistencies in infection rate and distribution data, and a dearth of
information regarding strain-level genomic variation. The central hypothesis of this project is that high-resolution
data on infection rate and genomic population substructure will elucidate R. buchneri's trajectory toward an obligate
endosymbiotic lifestyle. The proposed work will gauge the extent of species-specific innovation in R. buchneri by
using 1) long-read sequencing to generate a closed genome, 2) RNA-seq to confirm pseudogene prediction, and 3)
phylogenomics to characterize genes and other genomic elements unique to R. buchneri (AIM 1). The current
proposal work will also characterize the R. buchneri pan-genome by using 1) quantitative PCR to assess its infection
rate among natural populations of deer ticks, 2) short-read deep sequencing to determine the distribution of R.
buchneri genetic variants, alleles, and MGEs, and 3) phylogenomics to characterize the extent (and origin) of lateral
gene transfers into R. buchneri (AIM 2). Illuminating R. buchneri genomic variation and tick infection frequency will
lead to insights into its relationship with the deer tick and ultimately inform future efforts to use its repertoire of MGEs
as gene drive tools for spreading factors to combat tick-borne diseases.

Public health relevance
Project Narrative The goal of this proposal is to explore the role of genetic variation – particularly mobile genetic elements (MGEs) – in shaping the curious ecological relationship between an intracellular parasite (Rickettsia buchneri) and its sole known host, the deer tick (Ixodes scapularis). Our proposed research stems from our prior characterization of several novel characteristics of the R. buchneri genome, including nine Rickettsiales Amplified Genetic Elements (RAGEs) and a preponderance of pseudogenes, as well as R. buchneri's prevalence in (and apparent restriction to) deer ticks; as such, our experiments will 1) assess the nature of R. buchneri pseudogenization and species-specific innovation, and 2) determine the infection rate of R. buchneri in deer ticks and characterize its pan-genome. Our work will impact human health by informing future efforts aimed at exploiting R. buchneri MGEs as gene drive tools for spreading factors to combat I. scapularis-borne human diseases.